Promoting diversity through sub-cellular mass spectrometry discoveries: metabolic encoding of the embryonic body plan

This project is designed to enhance the diversity of the biomedical research workforce. A PhD Graduate
Student from underrepresented backgrounds will be trained to enable their original research and career
development at the frontiers of chemistry and biology. The trainee will learn advanced bioanalytical chemistry
and vertebrate embryology using the frog Xenopus laevis as model, while elucidating the mechanism of action
underlying cell fate changes by small molecules called metabolites. Our understanding of molecular
mechanism orchestrating the patterning of the embryo requires knowledge of all the molecules produced as
the zygote differentiates into the three primary germ layers of the embryo. Decades of research and innovative
embryological manipulations have identified and revealed the functions of many genes and transcripts.
However, very little is known about the contribution of metabolites to the formation of the intercellular
communication and the long-term development of the embryo. The proposed training–research program fills
this knowledge gap in technology and biology by providing the PhD Graduate Student with training to conduct
original research at the chemistry-biology interface. The student will develop skills in bioanalytical chemistry,
specifically quantitative metabolomics by capillary electrophoresis and ultrasensitive electrospray ionization
mass spectrometry to enable the characterization of the proteo-metabolomic states of embryonic cells and
tissues. Further, the student will also develop the required biomedical–biological skills to study the
developmental implications of cell fate decisions, including classical embryological manipulations, cell fate
tracking, and Xenopus laevis biology. The outcomes of this interdisciplinary approach will help illuminate the
role of the metabolome for the establishment of these important precursor cells and tissues. Because these
molecular processes are highly conserved across vertebrates, the data collected from Xenopus are likely to
have high relevance to human structural birth defects. The new biochemical information that will be obtained in
individual embryonic cells and their progeny (cell lineage) at several critical developmental time points will also
improve other research fields that study cell differentiation (e.g., of stem cells) and the developmental origins of
adult disease. This project will provide immersive cross-disciplinary training–research experience to enable the
student to pursue an independent career while diversifying the biomedical research workforce.

Public health relevance
Development of the vertebrate embryo requires a complex symphony of small and large molecular changes, one cell at a time. This work will train a PhD graduate student to employ new-generation technologies from chemistry to study how proteins and metabolites underlie cellular decisions to form tissues using the frog as developmental model. This project is designed to promote Diversity in the US biomedical work force as well as to better public understanding of cell differentiation and embryonic development.